STRUCTURAL ANALYSIS OF SYNTHESIZED N-GLYCOSYL ASPARAGINE DERIVATIVES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This research is being undertaken in collaboration with Dr. Gary F. Clark. Dr. Clark is responsible for the synthesis and purification of N-linked glycosyl asparagine derivatives. We are performing structural analysis of the compound prepared by Dr. Clark.